DP21-001 Kansas PRAMS Project

Kansas PRAMS: Component A (Core Surveillance)
Project Summary/Abstract
The Kansas Pregnancy Risk Assessment Monitoring System (PRAMS) is a collaborative project
with the Centers for Disease Control and Prevention (CDC) to establish a state-specific,
population-based, surveillance system of maternal health, behaviors, and experiences during
preconception, pregnancy, and postpartum. Kansas PRAMS provides data to inform a variety of
maternal and child health issues. Two major goals of Kansas PRAMS are to reduce maternal
and infant morbidity and mortality, and reduce low birth weight.
Specific objectives of the Kansas PRAMS study include:
1. To implement population-based surveillance within Kansas on selected maternal
behaviors and experiences that occur prior to, during, and shortly after pregnancy
among women with a recent live birth, including emerging issues and post-disaster
surveillance needs, as they arise.
2. To ensure data is of high scientific quality and comparable to other jurisdictions by
following the methodology documented in the CDC PRAMS protocol.
3. To conduct comprehensive analyses of PRAMS data based on a written state-specific
analysis plan designed to inform programmatic activities, research, and public health
practice.
4. To translate and disseminate analytic results into useable information for public health
action that can guide program development and evaluation, in collaboration with a state-
level steering committee.
PRAMS contacts new mothers two to three months after delivering a live birth. The sample is
drawn from the Kansas birth certificate file. Mothers from this sample are mailed a survey
questionnaire. If mothers do not respond by mail, phone interviewers attempt to interview them
by phone. Incentives and rewards are used in an effort to maximize participation in the study.
Kansas PRAMS will provide quality, statewide, population-based surveillance data to inform the
Kansas Title V Maternal and Child Health Priorities for the next five years. The data will further
the Kansas Department of Health and Environment's mission to “protect and improve the health
and environment of all Kansans.”

Public health relevance
Kansas PRAMS: Component A (Core Surveillance) Project Narrative Kansas Pregnancy Risk Assessment Monitoring System (PRAMS) is a population-based survey that collects information on Kansas mothers who have recently given birth to a live-born infant. The survey asks information about their experiences, behaviors, and attitudes before, during, and shortly after pregnancy. The PRAMS data are used to identify groups of women and infants in Kansas at high risk for health problems, to monitor changes in health status, and to measure progress towards goals in improving the health of mothers and infants.